Targeting insomnia to improve outcomes in adults with problematic cannabis use

Cannabis use, heavy cannabis use, and cannabis-related problems are becoming increasingly common in the
United States. Among those who use cannabis regularly, significant insomnia is common. For example, our
data from 800 patients seeking medical cannabis indicate that insomnia is a chief comorbidity, with 80% of
participants reporting that they regularly use cannabis to manage symptoms of insomnia. In addition, sleep
problems are often a barrier to reducing cannabis use among those with Cannabis Use Disorders. Cognitive
Behavioral Therapy for insomnia (CBTi) is highly effective in individuals with insomnia comorbid with other
health conditions, including those with heavy and/or problematic use of substances; although it has not been
fully tested in those with problematic cannabis use. In a recently-completed National Institute on Drug Abuse
R34 randomized controlled pilot trial, our group found that, compared to a telemedicine-delivered Sleep
Hygiene Education (SHE-TM) condition, a tailored telemedicine-delivered CBTi (CBTi-CB-TM) improved
insomnia and daytime functioning and reduced cannabis use more during short-term follow-up among non-
treatment-seeking adults using cannabis for sleep. In addition to important clinical questions related to the
treatment of insomnia in those who use cannabis, the specific mechanisms linking heavy cannabis use and
insomnia are poorly understood. We propose to evaluate whether a fundamental sleep regulatory system –
homeostatic sleep drive – is dysregulated in subjects with problematic cannabis use and whether changes in
this mechanism are associated with clinical outcomes. Thus, the aims of the proposed study are to recruit a
sample of 200 adults with problematic cannabis use and insomnia to evaluate (1) the efficacy of CBTi-CB-TM
vs. SHE-TM for sleep, cannabis use, and associated daytime symptoms and (2) the effects of CBTi-CB-TM on
the homeostatic sleep system and its association with clinical outcomes. Building on the success of the recent
R34, the proposed study will examine the longer-term outcomes associated with randomization to CBTi-CB-TM
and utilize state-of-the-art measures of sleep homeostasis to examine the factors underlying the links between
cannabis use, contents of the intervention, and objective sleep outcomes. These findings have important
implications for understanding the relationship between cannabis use and sleep, as well as for identifying
strategies to help improve outcomes in the large and growing group of individuals who report problematic
cannabis use and sleep problems.

Public health relevance
As heavy cannabis use becomes more common in the United States, it is essential to understand the common problems associated with cannabis use, such as poor sleep, and whether targeting co-occurring problems can reduce levels of cannabis use and improve functional outcomes. Emerging data indicate that insomnia and/or use of cannabis for sleep are very common in those with problematic cannabis use. The present study will evaluate the longer-term efficacy of a Cognitive Behavioral Therapy intervention on cannabis- and sleep- related outcomes in adults with problematic cannabis use and insomnia while also studying a potential mechanism underlying the link between cannabis use and sleep.